Mu Opioid Receptors and Splice Variant Expression in Neonate Autoresuscitation

Project Summary/ Abstract
Sudden Infant Death Syndrome takes the lives of approximately 1,400 infants annually under the age of one and
its etiology remains mostly unknown. Currently SIDS is explained via the triple risk model that proposes that
SIDS occurs in a vulnerable infant during a critical developmental period when triggered by an external stressor,
including failure of the neonate autoresuscitation reflex. Opioid receptors are expressed in brainstem regions
that are integral for respiratory regulation and are known to contribute to respiratory dysfunction when
homeostatic signaling is disrupted. Previous literature has identified an association between a mutation in the
OPRM1 gene encoding mu opioid receptors (MORs) and SIDS cases, however, investigation of how this gene
and perturbations in its SIDS associated variant of unknown significance modulates respiratory regulation are
poorly understood. In the following aims, I will test the hypothesis that native OPRM1 function is integral to
protective neonate respiratory reflexes and that an OPRM1 SIDS associated nucleotide variant negatively affects
the neonatal autoresuscitation reflex. Aim 1: Does the loss of OPRM1 modulate the neonatal autoresuscitation
reflex and respiratory dynamics following anoxic gas challenges? Aim 2: Determine the role of the 6
transmembrane (6TM) OPRM1 MOR variants in neonatal breathing and the protective autoresuscitation reflex.
To test these aims, I will utilize genetic knockout (KO) mouse models to manipulate global OPRM1 expression
and expression of specific classes of OPRM1 spice variants. For example, the OPRM1 exon 2 KO mouse model
produces mice that do not express OPRM1 whereas the exon 11 and exon 1 KO mouse models only produce
full length 7 transmembrane (TM) MOR variants or truncated 6TM variants, respectively. For functional
characterization of respiratory dynamics, mice will be challenged with repeated sessions of hypercapnic anoxia
to test their autoresuscitation reflex. For assessing network structure and cellular activation patterns, quantitative
spatial transcriptomics will be applied to brainstem tissue of OPRM1 exon 2 KO, exon 11 KO, and exon 1 KO
neonatal mice that have been challenged with bouts of sublethal hypercapnic anoxia. Determining the neuronal
mechanisms of OPRM1 in the neonatal autoresuscitation reflex will provide crucial insight into risk factors
contributing to congenital diseases including SIDS and NAS and may aid in the development of therapeutic
interventions. This study will progress the field by elucidating the role MORs in respiratory regulation and
dysfunction as well as its potential contribution as a risk factor to congenital diseases when expression is
perturbed. This work will significantly aid in identification of the neuronal mechanisms and molecular targets
involved in respiratory dysfunction underlying disease. The training plan and environment that accompany this
proposal comprise of scientific and professional development courses, workshops, scientific seminars, and an
environment enriched with technology at the forefront of the field which will provide a provident foundation for a
transition to research independence.

Public health relevance
Project Narrative Sudden Infant Death Syndrome (SIDS) remains the leading cause of infant death in infants less than one year of age and its etiology remains vastly unknown. Mu opioid receptors (MORs) play a crucial role in respiratory regulation and recently a case study identified that a mutation in the OPRM1 gene that encodes a truncated splice variant of MORs was associated with SIDS, suggesting that this gene may be implicated as a risk factor for SIDS etiology. We aim to determine the requirement of the OPRM1 gene and its 6 transmembrane MOR splice variants in the neonatal autoresuscitation reflex, hypothesized to be a common endpoint for many SIDS cases, and respiratory dynamics by utilizing OPRM1 knockout mouse models to uncover molecular targets contributing to SIDS pathology and potential markers for therapeutic intervention.